Special Projects: Analytical Track 2: NFSDX and ORAPP

SUMMARY: SPECIAL PROJECT TRACK 2 (NFSDX INTEGRATION AND ORAPP ADOPTION) Realizing the revolutionary promise of large-scale systematic food surveillance depends on increasingly automated and integrated electronic data management systems to be developed and implemented. The core tenet of this large and multifaceted proposal is to contribute a comprehensive and integrated food protection laboratory hub to the Food Emergency Response Network (FERN) that is capable of analyzing many different foods across a diversity of threat priorities, and communicate its results rapidly and efficiently. Implementing automated sample entry, real-time data deposition, and seamless electronic results reporting is central to achieving our goal of ensuring a safe food supply. Currently the MDH Laboratories Administration reports FERN testing results manually through eLEXNET. The information technology modernization that is currently underway at the MDH Laboratories Administration is an ideal opportunity to integrate systems for seamless reporting of results obtained under this cooperative agreement. We therefore seek to partake in Special Project Track 2 to integrate our data reposting systems to the Food and Drug Administration. Specifically, our activities in the first year of this cooperative agreement will be focused to achieve the prescribed Specific Aims for this track.